VASOCONSTRICTION DURING COLD PRESSOR TEST--EFFECTS OF ALPHA ARENERGIC BLOCKADE

Describe the effects of the alpha-adrenergic antagonist phentolamine on vasoconstriction in the presence and in the absence of a cold stimulus.